Genome Technology Center

PROJECT SUMMARY/ABSTRACT
The Genome Technology Center (GTC) is a state-of-the-art, heavily utilized shared resource that provides
expert, affordable, cost-effective, rapid turnaround genomic services to all Perlmutter Cancer Center (PCC)
investigators and their collaborators across all New York University (NYU) campuses. GTC is essential to the
research of the 4 Research Programs, as genomic analyses are central to most modern cancer research. During
the funding period, 111 funded grants and 144 publications used GTC data, many co-authored by the director
and key scientific staff. GTC is directed by Dr. Adriana Heguy, PhD, Professor of Pathology and Associate
Dean for the Shared Resources at the Office for Science and Research at NYU Langone Health. She has more
than 25 years of experience in genomics, 15 years of experience running core facilities at two institutions, and
an international reputation in the field. She is assisted by 9 highly trained, expert scientists at the Masters’ and
PhD levels. GTC resides in newly renovated, expanded space with a separate sequencing room, an automation
suite, office space, and a small conference room that can be used by all PCC Shared Resources. Services
offered include automated library preparation, short- and long-read sample preparation for a variety of
applications such as whole genome and exome sequencing, bisulfite sequencing, RNA-Seq, single cell multi-
omics sequencing, spatial transcriptomics, and multiple epigenomic and chromatin conformation approaches.
GTC also educates PCC faculty, staff, fellows, and students who are interested in learning how genomic
technologies can advance their research careers. GTC continuously grows and updates its instrument fleet to fit
the needs of all PCC members and assesses client satisfaction via surveys and an internal advisory board. The
Specific Aims of GTC are: 1) To provide a wide range of expert genomic services, including automated library
preparation, sequencing, and to evaluate and implement emerging genomic technologies in order to continue
providing state-of-the-art support for PCC members, 2) To facilitate genomic data sharing and storage through
high performance computing (HPC) secure servers, including FASTQ file generation, analysis pipeline running
and distribution of data to PCC investigators and bioinformaticians, and 3) To educate and inform members of
the PCC community on genomic technologies and their use for cancer research through frequent informational
and training seminars.